Enhancing adherence and completion of the three-month isoniazid with rifapentine (3HP) tuberculosis preventive therapy regimen through biomarker-guided adherence counselling

PROJECT SUMMARY/ABSTRACT
The overall goal of this Emerging Global Leader Award (K43) project is to support Dr. Dickens Onyango’s
research and enable him to acquire additional skills to transition to an independent scientist focused on
tuberculosis (TB) prevention among people with HIV through innovative approaches. The proposed study
intends to develop and evaluate a urine dipstick-guided counseling intervention to support adherence and
completion of the three-month isoniazid with rifapentine (3HP) tuberculosis preventive therapy (TPT)
regimen. This award will allow Dr. Onyango to achieve his training goals to: 1) Acquire expertise in qualitative
research and mixed-methods analysis; 2) Gain advanced knowledge and hands-on experience in
randomized controlled trials; 3) Develop proficiency in assessing implementation outcomes using the Proctor
Implementation Outcomes framework. Building on his expertise in TB and HIV epidemiology and
implementation science, Dr. Onyango will receive mentorship from a multidisciplinary team of mentors and
collaborators with expertise in HIV/TB clinical research, human-centered design, qualitative methods,
randomized controlled trials (RCTs), and implementation science. This award will enable him to develop into
a leading investigator in clinical and implementation research at the intersection of TB and HIV. Despite the
availability of effective TB preventive therapy regimens, adherence remains suboptimal, hindering the impact
of these interventions. Although the need to improve adherence to TPT regimens has been identified by the
World Health Organization and the Kenya Ministry of Health, effective strategies to enhance adherence
remain limited. Biomarker-guided counseling has shown promise in improving adherence to HIV pre-
exposure therapy but has not been explored in improving adherence to TPT. Robust evidence is needed
evidence on the effectiveness of such strategies in routine settings. Additionally, policymakers need data on
the real-world impact of these approaches, including their acceptability, feasibility, fidelity, and cost, to inform
scale-up. The overall goal of the proposed study is to develop a dipstick-guided adherence counseling
intervention, evaluate its effectiveness in improving adherence and completion of 3HP, and assess its
implementation outcomes. Using a phased implementation approach, the specific aims are to: 1) develop the
intervention using human-centered design 2)Assess the effectiveness of dipstick-guided adherence
counseling in improving adherence and treatment completion of 3HP among PLHIV in a randomized
controlled trial; 2) Explore the acceptability, feasibility, fidelity, and cost of this approach using mixed-methods
evaluations. This work will generate critical pilot data for a subsequent R01 application to assess the impact
of the proposed intervention in improving adherence and completion of 3HP using a cluster randomized
design. The findings will advance evidence-based strategies for improving adherence to TPT and improving
outcomes among PLHIV, contributing to global TB elimination goals.

Public health relevance
PROJECT NARRATIVE Although tuberculosis (TB) preventive therapy (TPT) reduces the risk of TB disease among people living with HIV by up to 60%, adherence to TPT regimens, including three-months of weekly isoniazid with rifapentine (3HP) remains suboptimal, with nearly 20% of PLHIV not completing the TPT course. Strategies for improving adherence to TPT remain limited. This project proposes to develop a dipstick-guided adherence counseling intervention, assess its effectiveness on improving adherence and 3HP completion in a randomized controlled trial and assess its acceptability, feasibility, fidelity, and cost.